Role of CD8 T cell-mediated Pathology in Globoid Cell Leukodystrophy

Abstract
Globoid cell leukodystrophy (GLD) or Krabbe's disease is a fatal genetic demyelinating disease of the central
nervous system affecting 1 in 100,000 live births with no cure or effective long-term treatment. GLD is caused
by loss-of-function mutations in the galactosylceramidase (galc) gene, where loss of GALC enzymatic function
results in toxic accumulation of its substrate, a lipid called galactosylsphingosine or `psychosine'. Psychosine
cytotoxicity is considered the basis of several key pathologies in GLD. Neuropathology in GLD is marked by
profound demyelination and inflammation. However, molecular details of these processes are limited, leaving
few therapeutic options. Early histological evidence for CD8+ T cells within demyelinated lesions in both the twi
mouse brain and human GLD brain had suggested a role for adaptive immunity in this disease. However, the
function of CD8+ T cells in GLD has not been previously determined. To address this gap in our knowledge, we
analyzed the timing of T cell population changes by flow cytometry in CNS tissues from the twitcher mouse
model of GLD and compared with wt littermates. We identified a rapid and protracted elevation of T cells in the
twi CNS that was coincident with the onset of clinical disease at postnatal day 21 (P21). These data were
confirmed using single-cell RNA sequencing on twi and wt littermate brain tissues from which identified a 9-fold
increase in CD8+ T cells in twi mouse brains at P21. Our transcriptomic data also defined the CD8+ population
as cytotoxic T lymphocytes (CTLs). To test the function of CD8+ CTLs in GLD-like disease in twi mice, we
depleted CD8+ T cells by administering anti-CD8 antibody to twi mice and found that this treatment effectively
prevented disease onset, preserved wellness and completely prevented CNS demyelination while also
attenuating pro-inflammatory cytokine levels in brain and blood. These novel and highly translational data
portend a pathogenic role for CD8+ T cells in GLD and underlie the basis for our overall hypothesis that CD8+
T cells are pathogenic in GLD and directly contribute to disease. Accordingly, Aim 1 will characterize the
spatial and temporal development of CD8+ T cells in twi mice and challenge the contribution of CD8+ T cells
using knockout mouse lines to then assess clinical, biochemical, and pathological outcomes. Aim 2 will define
the overall nature of adaptive immunity by evaluating contribution of CD4+ T cells to CD8+ T cell-mediated
immunity in twi mice using targeted depletion and genetic strategies. Aim 3 will identify and profile the timing,
and location T cells responding to authentic antigen, the clonality of the T cells using T cell β chain VDJ
phenotyping, and then identify the nature of the antigen presenting cell types using transgenic reporter mice.
These multi-disciplinary studies will interrogate a previously unrecognized CD8+ T cell neuroinflammatory
response in GLD. Outcomes of these studies are expected to fill an important gap in our understanding on the
fundamental cellular pathological mechanisms underlying the development CD8+ T cell mediated
neuropathology and disease in GLD.

Public health relevance
Project Narrative Globoid cell leukodystrophy (GLD) is an incurable genetic disease of the central nervous system that is recognized by profound white matter loss (demyelination), neurodegeneration and inflammation. Using genetic profiling technology, we have determined that this disease is distinguished from healthy, non-disease nervous tissues by a prominent CD8 T cell population which has an untested contribution to this disease. Based on our strong preliminary data which demonstrate that blocking these T cells we can effectively prevent disease, this project will interrogate the role of CD8 T cells, by applying advanced genetic tools including transgenic animals and unbiased RNA sequencing approaches, to determine how these adaptive immune cells with strong pathogenic potential are involved in GLD.